RESEARCH AND MENTORING EXCELLENCE IN DIVERSE AND INCLUSIVE ENVIRONMENT

PROJECT SUMMARY/ABSTRACT
Thyroid cancer is the most common endocrine malignancy and incidences are rising. Thyroid cancers of
follicular cell origin stand out among solid tumors because many of the tumor -initiating genetic events are
known. Activating mutations of effectors of the MAPK signaling pathway are associated with both follicular and
papillary thyroid cancer, and occur throughout the spectrum of thyroid diseases from benign adenomas
through therapeutically refractive poorly-differentiated disease. Despite sharing activation of the MAPK
pathway, activation via different effectors in the pathway results in distinct and unique pathological outcomes,
including metastasis to distinct distant sites. We do not understand how activation of a single pathway via
different mutations within the signaling cascade results in different pathological outcomes and recruitment of
different tumor microenvironments. This paradigm is seen not only in thyroid cancer, but in other
malignancies. We will utilize recently generated mouse models of thyroid cancer to model follicular and
papillary thyroid cancers to study how activation of the oncogene Hras versus Braf affects tumor development
and can modify the tumor microenvironment. We hypothesize that mode of activation contributes to stromal
recruitment and extracellular matrix (ECM) modification, thus contributing to the pathobiology of tumor
formation and progression. The data generated in these studies will provide a better understanding of the
mechanisms by which different oncogenic events that activate the same pathway predisposes the
development distinct pathological outcomes. We hope to use these data to develop novel therapeutic and
prevention strategies for thyroid cancer.

Public health relevance
PROJECT NARRATIVE PARENT AWARD This proposal seeks to answer how activation of the same signaling pathway, MAPK pathway, via different proteins in the cascade affects the molecular mechanisms of cancer development and can modify the tumor microenvironment. The overall objective is to identify novel therapeutic targets within the microenvironment, with a secondary objective to determine how how different activating mutations of the same pathway changes recruitment and modulation of the tumor microenvironment. The outcome of the proposed studies can impact clinical practice paradigms and lead to the development of novel therapeutic and prevention strategies for thyroid cancer.